Research Program

RESEARCH PROGRAM PROJECT SUMMARY
The Research Program will address the grand challenge of advancing implementation science to
improve cancer screening and prevention in underserved populations by developing and conducting
rapid cycle testing of innovative approaches to implementing evidence-based interventions (EBIs). The
partnership between the BRIDGE-C2 Center's Research Program and Implementation Laboratory will facilitate
and accelerate robust and relevant science to address disparities in cancer screening and prevention. To
accomplish this, the Research Program will establish an Implementation Studies Unit and a Methods Unit.
These units build upon extensive expertise in conducting implementation science research and in developing
and applying novel, mixed methods approaches to cancer screening and prevention issues in partnership with
and in primary care. The Center will also conduct four initial pilots in the Implementation Laboratory and use
emergent findings to inform future projects. We selected two research pilot projects to study the
implementation of interventions designed to increase rates of (1) cervical cancer screening (Pap tests) and
follow-up care and (2) improve tobacco cessation support. Following a similar engaged approach, the two
Methods Pilots will assess how to precisely design and tailor HIT tools and other implementation strategies for
a diverse group of member practices, which is a high priority for the Implementation Laboratory. These pilot
projects that emerged from engagement of a multidisciplinary team of stakeholders serve as the initial seeds
from which to launch the Center and to build new knowledge, methods, and capacity to improve cancer
screening and prevention in CHCs. The multi-disciplinary leadership of the Research Program will establish
processes, new expectations, and capacity for discussing data and trends (including use of visual techniques
and stories to ensure conversation and engage a wide and varied group of stakeholders), and, develop and
prioritize new project ideas, and rapidly and broadly disseminate findings. The Center has the capability to
design studies with sustainability in mind, and develop and test innovative interventions that promote
maintenance of an EBI to inform when `boosters' are needed, and minimize regression to the mean, which is
common in practice change and implementation work. The Research Program infrastructure is designed to
identify, implement, and disseminate strategies in primary care settings that are most effective in improving
sustained implementation of cancer screening and prevention EBIs with the ultimate goal of reducing health
disparities.